Targeting the transcriptionally-active reservoir to reduce chronic inflammation in aged people with HIV

PROJECT SUMMARY
Recent data suggest that a substantial fraction of the HIV reservoir persisting in the face of antiretroviral
therapy (ART) is transcriptionally active and may contribute to the chronic inflammation observed in people with
HIV (PWH). This is particularly pertinent in elderly PWH, who exhibit additional elevated inflammation and co-
morbidities due to the aging process itself. Surprisingly, immune differences between the sexes prove largest
after the age of 65, an unexpected observation given that the menopausal transition in women (typically occurring
between the ages of 45-55) decreases estradiol to levels similar to those of men. The extent to which biological
sex and sex steroids impact the HIV reservoir and chronic inflammation in elderly PWH has not been sufficiently
studied. In this proposal, we will deeply characterize the transcriptionally-active HIV reservoir in aged ART-
suppressed men and women with HIV, determine how these cells contribute to chronic inflammation, and identify
novel ways to block their ongoing viral gene expression. We will leverage the infrastructure of the MACS/WIHS
Combined Cohort Study (MWCCS), and include not only virally suppressed men and women with HIV, but also
those with non-suppressible viremia (NSV) as extreme cases of HIV transcriptional activity in the face of ART.
In Aim 1, we will use our newly developed single-cell sequencing-based technology, HIV-Seq, to compare the
phenotypes, transcriptomes, and clonal expansion history of transcriptionally-active reservoir cells between
elderly male and female participants, and between different tissue sites from aging women with HIV. In Aim 2,
we will use multiple “omics” technologies (CyTOF, Olink) to test the hypothesis that ongoing HIV gene expression
drives chronic inflammation by fueling expansion of HIV- and CMV-specific CD4+ T cells harboring
transcriptionally-active HIV. In Aim 3, we will identify novel ways to block ongoing HIV gene expression by
targeting the accessory protein Tat, and test the consequences of this blockade in primary cell models and using
patient specimens. Collectively, our aims will help develop strategies to prevent the expansion of the
transcriptionally-active reservoir in aging male and female individuals living with HIV and identify drugs that
durably silence HIV expression in reservoir cells. Our inclusion of post-menopausal women is a notable
innovation, as women have been historically understudied even though they shoulder a large burden of the HIV
epidemic.

Public health relevance
PROJECT NARRATIVE While effective at suppressing HIV replication, current antiretroviral therapy (ART) does not eliminate the persistent HIV reservoir nor prevent HIV gene expression from “active” reservoir cells, which can result in low- level chronic inflammation. This may be particularly problematic in aged people with HIV, who exhibit additional low-level inflammation due to the aging process itself. Here, using blood and tissue specimens from aged ART- treated men and women with HIV, we propose to characterize the phenotypic and transcriptional features of “active” reservoir cells, to study the mechanisms by which ongoing HIV gene expression can promote viral persistence and chronic inflammation, and to identify and test novel drugs that prevent ongoing HIV gene expression.